Role of LSD1 in Triple Negative Breast Cancer Development and Therapeutic Response

PROJECT SUMMARY/ABSTRACT
About 10-20% of breast cancers are triple-negative breast cancers (TNBC), which have a poorer prognosis and
worse clinical outcome than other types of BC. Due to the lack of target therapies, chemotherapy remains the
mainstay of treatment of TNBC, but acquired resistance often develops followed by metastasis and mortality.
This supplemental project is closely relevant to the ongoing research proposed in the parent grant R01CA260357
and significantly extends the scope of the current project. Our recent study demonstrated that LSD1 depletion
significantly reduced the incidence of BRCA1-deficiency induced mouse mammary gland tumors. Based on this
finding, we hypothesize that LSD1 overexpression is essential for breast cancer initiation and development due
to BRCA1 loss. In Aim 1, we will validate our preliminary findings and characterize the functional role of LSD1 in
BRCA1 mutation mediated TNBC progression. We will also investigate if LSD1 overexpression contributes to
PARPi resistance. Furthermore, we will explore the in vivo roles of LSD1 in tumor progression using xenograft
and mammary gland BRCA1 deficient TNBC mouse models. Cumulative evidence has suggested that epigenetic
silencing of a subset of cytotoxic T-cell lymphocyte (CTL) attracting chemokines (e.g. Th1-type CXCL9 and
CXCL10) plays an important role in shaping the tumor-promoting immune environment. However, the exact
epigenetic mechanisms underlying chemokine silencing are still unclear. Our recent studies showed that LSD1-
mediated silencing of CTL chemokines is associated with H3K4 demethylation at proximal promoter regions.
Tissue Factor Pathway Inhibitor 2 (TFPI2), a tumor suppressor gene, was identified as a key LSD1 targeted
gene. Induction of TFPI2 by LSD1 inhibition downregulates activity of matrix metalloproteinases (MMPs) and
promotes stability of chemokines, leading to enhanced CD8+ T-cell infiltration in tumors. Based on these new
findings, we hypothesize that overexpression of LSD1 facilities TNBC progression through promoting immune
suppressive environment. In Aim 2, we will characterize the crosstalk between epigenetic changes and TNBC
immune environment and further elucidate the molecular basis of LSD1-medicated chemokine silencing in
promoting TNBC progression. The proposed studies are expected to provide key preclinical data, novel
mechanistic insight, and rationales to address mechanistic and clinical associations between epigenetic defects
and TNBC tumor environment and tackles a significant clinical problem. Thus, this project has high scientific
significance and clinical relevance.

Public health relevance
Project Narrative This diversity supplemental fund application is closely relevant to the ongoing research proposed in the parent R01 grant and significantly extends the scope of the main project, which will further investigate roles of a key histone modifier LSD1 in breast tumorigenesis and tumor microenvironment. The results from the proposed studies are expected to provide key preclinical data, novel mechanistic insight, and rationales to address their mechanistic and clinical associations between epigenetic defects and TNBC tumor microenvironment. In the long run, these studies may lead to new and improved therapies for patients with relapsed and refractory TNBC.